Clickable Extracellular Vesicles to Silk-Based Biomaterials for Regenerative Medicine

PROJECT SUMMARY
Successful regenerative medicine approaches require harnessing the appropriate cell signals at the
right time to direct host tissue functions. These signals are often informed by the natural regenerative
processes controlled during development and homeostasis by mesenchymal stem cells (MSCs) and
their secreted extracellular vesicles (EVs), which allow a cell-based yet cell-free approach for
downstream regenerative technologies. This multidisciplinary, MPI proposal brings together a team of
two senior investigators leading regenerative medicine-focused group with complementary strengths,
co-investigators with critical roles, and industrial partner RoosterBio, Inc. Together, we will create and
test an innovative enabling technology to stably incorporate EVs to a biomaterial intended for tissue
engineering and regenerative medicine applications. Specifically, we will use a novel azide-based click
chemistry technique to controllably immobilize EVs to silk fibroin as a demonstrative application, but
immobilization can also be done on other biomaterials, substrates, or surfaces, or even tissues. We
chose silk as our biomaterial in this application given its FDA-approved status and wide use.
We hypothesize that “azide-clickable" MSC-derived EVs (which we will refer to simply as “Az-EVs”)
will have more stable immobilization to silk fibroin biomaterials than unmodified EVs, and this will result
in higher regenerative potency. To test this hypothesis and provide proof-of-concept applications, we
will pursue four specific aims:
Aim 1 - Demonstrate and validate Az-EV immobilization to silk fibroin-based materials;
Aim 2 - Demonstrate the MSC-mimicking effects of Az-EVs immobilized to silk in vitro;
Aim 3 - Demonstrate the regenerative effects of Az-EVs in a mouse chronic wound healing model;
Aim 4 - Demonstrate the regenerative effects of Az-EVs in a rat tissue engineered vascular graft model.
Partner RoosterBio, Inc. will “industrialize” (scale-up) the production of MSC-derived Az-EVs for
commercialization to make available to other researchers and clinicians.
This research will provide insight to the efficacy of this novel selective EV immobilization
technology to efficiently direct EV delivery within a biological system of interest. Our proof-of-concept
studies will demonstrate how utilization of this regenerative technology can aid in treating chronic
wounds and enabling TEVGs with improved patency rates.

Public health relevance
PROJECT NARRATIVE The next generation of technologies for regenerative medicine application will be fueled by cell- derived, self-packaged therapeutics known as extracellular vesicles (EVs). We will develop a process that makes these nano-sized therapeutics attachable to a biomaterial, like Velcro®, for tissue repair and regeneration. Additionally, our industry partner will modify their workflow to make the attachable EVs widely available and easy to use for downstream consumers, including those that are advancing regenerative medicine.